Genetic basis of diet-dependent responses across the lifespan

Project Summary:
C. elegans respond to changes in food availability, environmental conditions, and bacterial diets through nervous
system integration of sensory information and coordinated behavioral, physiological, and metabolic responses12,
13, 14. The laboratory and natural environments of C. elegans differ drastically in the bacterium present – the
laboratory environment relies on monocultures of E. coli, while the natural environment exposes C. elegans to a
wide variety of bacterial species including Bacteroidetes, Proteobacteria, and Actinobacteria1, 2. My recently
published study takes advantage of bacterial diets found in both C. elegans natural and laboratory environments
and provides a comprehensive assessment of changes in physiology and transcriptomic signatures as a result
to simply changing the bacteria diet worms were propagated on3. To my knowledge, this paper was the first
head-to-head comparison demonstrating how the natural environment controls physiology incongruously to that
of the laboratory environment, however, I realized that this study is just the beginning of understanding the
multiplexed relationship between dietary exposure and life history traits. The overarching goal of this proposal is
to reveal novel mechanisms of the complex food-based decision making to elucidate the underlying genetic basis
of diet-dependent responses across the lifespan. With two main approaches, I plan to take advantage of the
amenable C. elegans model and examine how two distinct physiological attributes, development and food
choice, can be differentially impacted by dietary exposure to lifespan-promoting bacteria. The first aim will be to
identify the neurocircuitry involved in deciding between two bacterial diets by developing unbiased food choice
assays (1a). With the use of these assays, I plan to identify the olfactory pathways involved with a combination
of neuronal ablation and genetic mutants (1b). Finally, I will examine how these mutations in the olfactory
pathways will influence C. elegans adaptive capacity and the multiple aspects of physiology that converge upon
aging and lifespan (1c). My second aim relies on genetics to examine how bacterial diet controls normal
progression of development. I plan to approach this aim by identifying developmentally slow mutants generated
by an ethyl methanesulfonate screen in order to reveal novel genetic regulators of developmental timing (2a).
Due to the high conservation of signaling pathways involved in dietary response, these studies will reveal new
insights into impacts diet has on health on longevity and stimulate future studies to use food as a nutraceutical
to combat the onset of aging and diseases.

Public health relevance
Project Narrative: C. elegans respond to alterations in food availability and environmental conditions through coordinated behavioral, physiological, and metabolic responses controlled by nervous system integration of sensory information12, 13, 14. In a single host genetic background, C. elegans display an adaptive capacity to different bacterial diets found in both the laboratory and natural environments, which influences multiple aspects of physiology and converge upon aging and lifespan1, 2, 3. By examining developmental timing and food choice, I will reveal novel mechanisms of the complexities of food-based decision making to elucidate the underlying genetic basis of diet-dependent modulation of the multifaceted physiology in C. elegans.